Collaborative Research: EDGE CMT: Utilizing adaptive variation in predatory behavior to uncover the relationship between genes and complex behavioral phenotypes

Not Applicable

Public health relevance
Not Applicable